Understanding the neurodevelopmental effects of youth tackle football participation

ABSTRACT
Potential long-term effects of tackle football and other contact sports have created significant public health
concerns about the risk of childhood participation. Considering the retrospective and cross-sectional nature of
prior work, there are critical knowledge gaps regarding the causality of youth tackle football participation and
subsequent clinical outcomes that preclude decision-making at the patient and policy level. Further, modifiable
risk factors (e.g., neuromuscular control) may influence exposure to and thus, outcomes from football-related
neurotrauma, but prevention remains understudied. Here we overcome some of the previous barriers to progress
in this field by acquiring a “true baseline” for athletes before they begin their first season of tackle football and
following them longitudinally across the first year of participation. We received funding from Ohio State’s Chronic
Brain Injury Program and successfully collected pilot data on 50 youth tackle football players (ages 8-12 years);
these data form the basis of our current proposal. Aim 1 will identify risk factors for higher exposure to football-
related neurotrauma. We will measure football-related neurotrauma exposure in first-year youth tackle football
players during all practices and games using instrumented mouthguards. We will use handheld dynamometry to
measure neck strength and will measure neuromuscular control through visual, vestibular, and reaction time
testing. Aim 2 will determine the effects of football-related neurotrauma exposure on neurodevelopment in
children with no previous tackle football exposure. We will enroll children who are registered for, but have not
yet begun participating in youth tackle football, as well as children registered for non-contact sports and children
not playing any sports. Aim 2a will determine short-term changes in cognitive function and brain structure and
function caused by football-related neurotrauma exposure from pre-season to post-season. Aim 2b will
determine longer-term changes across the first year of participation by examining players during the off-season
just prior to the start of the next season. Aim 2c will determine what factors (e.g., football-related neurotrauma
exposure, exposure to adverse childhood events, pre-existing neurodevelopmental disorders) contribute to
differences from typical development. We hypothesize that youth tackle football exposes children to repetitive
neurotrauma during a period of rapid neurodevelopment, resulting in observable cognitive impairments and
structural and functional changes in the brain, most likely in attentional control networks. Our proposal combines
a state-of-the-art approach to determining the effects of football-related neurotrauma on neurodevelopment, a
productive collaboration with youth sports programs in Ohio, community engagement and outreach, and a
multidisciplinary team of experts. The societal and clinical impact of these findings cannot be overstated. In
quantifying football-related neurotrauma exposure (Aim 1) and its effects on neurodevelopment (Aim 2) across
the first year of youth tackle football participation, our expected outcomes will inform community stakeholders
and policy-makers in their appraisal of the cost and benefit of children participating in youth tackle football.

Public health relevance
Project Narrative Continued media coverage of the potential long-term effects of contact sports, such as tackle football, has created significant public health concerns about the risk of childhood participation. This study will provide critical contributions to our scientific knowledge on the neurodevelopmental effects of youth tackle football across the first year of participation and has the potential to provide a key understanding of the risks and benefits of participation. Thus, the proposed research is consistent with the Pediatric Trauma and Critical Illness Branch of the NICHD scientific priority to prevent adverse health outcomes and developmental sequelae in children by improving early detection and by identifying optimal time periods for prevention and intervention efforts of repetitive brain injuries.